Office of Collaborative Biostatistics

The Office of Collaborative Biostatistics provides a broad range of data analysis and consultation services to laboratories performing basic scientific research into the origin and growth mechanisms of cancer. Other major collaborative efforts include studies to identify important prognostic and treatment selection factors, evaluate diagnostic procedures, develop improved staging systems, and assist investigators in the design, execution, and analyses of major in vitro drug testing studies. The Office develops and implements new statistical designs and biometric methods related to the development and evaluation of new cancer.